Mechanisms of autoimmunity in myasthenia gravis

Summary of the funded parent award or project (R01AI114780)
Myasthenia gravis (MG) is an autoimmune disorder affecting neuromuscular transmission. MG patients suffer
from severe muscle weakness and increased muscle fatigability due to diminished neuromuscular signaling. MG
is caused by autoantibodies that target components of the neuromuscular junction (NMJ); in most patients this
is the nicotinic acetylcholine receptor (AChR). These AChR autoantibodies mediate pathology through three
mechanisms: (i) interfering with acetylcholine docking, (ii) internalization of the AChR, and (iii) activation of the
classical complement cascade leading to tissue damage. There is heterogeneity within the AChR disease
subtype that includes early-onset and late-onset MG (EOMG and LOMG), which is based on age of onset, sex,
and HLA-association. Although MG patients with different subtypes share similar disease presentations, the
underlying immunopathology may be distinct. This is well illustrated by the AChR EOMG and LOMG subtypes.
Notably, EOMG is characterized by a thymic lymphocytic infiltrate, which includes AChR-specific IgG, T cells,
and B cells (including AChR autoantibody-producers) that organize as tertiary lymphoid organs, resembling
germinal centers. In contrast, LOMG rarely includes thymic abnormalities. While details of the heterogeneous
immunopathology are lacking, a deeper understanding of the mechanisms underlying the differences is highly
important for both the patient and clinician. This is because treatments that are anticipated to work well in one
subtype may not have a biological basis for use in the other subtype(s). Non-responding AChR MG patients in
several recent clinical trials, including B cell depletion, and complement inhibition therapies, clearly highlight this
gap in our knowledge. Thus, our project seeks to investigate details of the divergent immunomechanisms
underlying the EOMG and LOMG MG subtypes. Our study is sharply focused on the B cells that directly
contribute to disease pathology, those which produce AChR autoantibodies. Using new approaches, we are
working to isolate these rare AChR autoantibody producing B cells from thymus tissue and blood and define their
repertoire characteristics. Human recombinant monoclonal antibodies (mAb) will then be produced from these B
cells so that molecular mechanisms of pathology can be defined using a suite of novel assays to identify their
ability to affect pathology through complement-directed tissue damage, blocking, or modulation. Finally, we will
define the phenotypes of autoantibody- producing B cell subsets and T helper cell subsets including those
specific for the AChR antigen. This study is designed to provide detailed insights into both the role of autoantigen-
specific immune cell subsets and molecular mechanisms used by autoantibodies to facilitate the pathology of
the EOMG and LOMG subtypes. These clearly defined immunomechanisms are expected to impact treatment
outcomes through informing application of biological therapeutics used to treat specific MG disease subsets.

Public health relevance
Project Narrative (R01AI114780) The overall goals of the application are to define the autoantibody-specific B-cell population, T-cell population subsets and pathogenic mechanisms underlying the acetylcholine receptor (AChR) subtype of myasthenia gravis (MG) using patient derived specimens.